Testing implementation strategies for evidence-based physical activity and nutrition education for preschoolers in SAGE

Title: Sustainability via Active Garden Education (SAGE): Scaling up evidence-based, policy-guided physical
activity and nutrition education for preschoolers
Sustainability via Active Garden Education (SAGE) is an evidence-based physical activity and nutrition
program that has been delivered in low-income serving, early care and education (ECE; preschool) sites in
Maricopa County, AZ. Gardens in ECE sites improve interest in and consumption of fruit and vegetables
among young children; teach important science, social, and motor development skills; engage families and
communities; and offer important outdoor learning opportunities. The overall objective of this project is to
compare how three different SAGE implementation strategies impact measures of implementation (primary),
sustainability (secondary), cost and child health outcomes (secondary). Strategies we will compare include (1)
SAGE (garden + online curriculum + materials box) vs. SAGE plus e-support implementation package
(text messages + newsletters + hotline), (2) SAGE with no in person support and training vs. SAGE with in
person support and training, and (3) SAGE usual activities vs. SAGE with a ECE virtual learning
collaborative to share SAGE implementation experiences and strategies with other ECE sites and community
partners. We will (Aim 1) apply the Consolidated Framework for Implementation Research (CFIR) to identify
inner and outer setting characteristics that hinder or facilitate SAGE implementation to tailor support
strategies for local context; (Aim 2) use the Multiphase Optimization Strategy (MOST) framework to analyze
SAGE implementation strategy components to determine the most efficient and effective combination of
strategies across contexts; and (Aim 3) investigate the potential for sustainability, costs and cost effectiveness
outcomes that may influence implementation strategies and their effect on locomotor skills and nutrition
effectiveness outcomes. In Aim 1 (MOST screening), we will measure ECE site and teacher characteristics via
an in person visual assessment and a teacher and director survey (inner setting). We will also complete a social
network analysis of ECE personnel. With this information we will use an implementation mapping process to
collaboratively develop and finalize implementation strategies. In Aim 2 (MOST refine), 32 existing SAGE ECE
sites will be pair matched by degree of individual implementation and site characteristics (size, enrollment)
assessed in aim 1, and assigned to one of eight implementation strategy combinations to a full factorial model.
Sites will be assessed at the beginning and ending of the academic year with site audits, parent and teacher
surveys, and non-invasive child fitness, physical activity, veggiemeter and eating in the absence of hunger
measures. For Aim 3, (MOST refine) the potential for sustainability, costs and cost effectiveness ratio for each
of the strategies will be calculated from a payer and societal perspective to determine which implementation
strategy or combination of strategies may be most scalable. Results will help inform decisions about garden
and curriculum implementation strategies that can be scaled for ECE sites in underserved communities.

Public health relevance
SAGE DI Project Lay Narrative/Public Health Relevance Gardens in early care and education (ECE) sites that serve underserved communities can increase physically active time and improve interest in and consumption of fruit and vegetables among young children; teach important science, social, and motor development skills; engage families and communities; and offer important outdoor learning opportunities. This study will optimize strategies to determine the most efficient and effective delivery methods for Sustainability via Active Garden Education (SAGE) designed to increase physical activity and nutrition programming in ECE sites to meet policy guidelines.